Society for Inherited Metabolic Disorders Annual Meeting

ABSTRACT
The Society for Inherited Metabolic Disorders (SIMD) requests support to provide scholarships for trainees to
attend its annual meetings in years 2023 to 2027. The 2022 meeting will be held in Orlando, FL April 10-13,
2022. The 2022 meeting will be supported by no-cost extension of the previous grant. The 2023 meeting will be
held in Salt Lake City, UT March 18-21, 2023 in conjunction with the American College of Medical Genetics
(ACMG) following their meeting. The 2024 meeting is TBD. The 2025 meeting will be held in conjunction with
the International Congress on Inborn Errors of Metabolism in Kyoto, Japan. The 2026 meeting is TBD. The 2027
meeting is TBD.
Inborn errors of metabolism (IEM) are an important cause of intellectual disability, cerebral palsy, neuromuscular
disease, cardiac disorders, hepatic and renal dysfunction, arthritis, diabetes, growth failure and blindness. As
the wide clinical and molecular spectrum of these disorders is being elucidated, in part fueled by the development
of tandem mass spectroscopy and the rapid expansion of newborn screening programs, the number of affected
individuals is now known to be much larger than originally recognized. In addition, therapies are available for
some conditions, but few clinical trials have been performed to evaluate their efficacy. Thus, much remains to
be done to better understand these severe disorders and develop effective treatments for them. For the U.S. to
remain pre-eminent in this important area of research, it is essential to attract young investigators into the field.
One effective mechanism to achieve this goal is to provide them with the opportunity to participate in the SIMD
meeting, where they can explore the field and develop scientific ties to other established investigators. The SIMD
meeting is held annually and participation, especially by young investigators, has been steadily increasing each
year. The availability of NIH travel awards has been a major reason for this increase. Trainees seeking funding
are required to submit an abstract describing original research to be presented at the meeting. We anticipate
submission of 40 abstracts for presentation at each meeting from trainees/young investigators with twice that
number for the international meeting (2025). Applications for travel awards will be competitively reviewed 4
months prior to each meeting, with the goal of making up 10 annual awards of $1,000 each for the national
meeting and up to 5 awards of $2,000 for the International meeting. Additional funds will be solicited from private
sources. Women and minority applicants will be actively recruited.

Public health relevance
PROJECT NARRATIVE The Society for Inherited Metabolic Disorders (SIMD) meeting will help to train young individuals to become investigators to enhance the research endeavors and to train new physicians to take care of patients with disorders of the body’s biochemistry. There are very few such specialists in the country and providing travel funds for new trainees to meet and present their research encourages them to remain in the field.